CORE--Physiology-Animal

Core B, the Physiology/Animal Care Core, will provide services related to the preparation of animal models used in the[unreadable] PPG including surgical preparation of the various pig, and mouse models and the health maintenance of these chronic[unreadable] animal preparations. Animal husbandry, including normal housing and feeding, will be carried out by the Research[unreadable] Animal Facility of UMDNJ - New Jersey Medical School. There are four major functions of Core B. The first component[unreadable] of Core B involves surgical preparation of the large animal models, which is required for Projects 1 and 2. The second[unreadable] component involves surgical preparation of the rodent models, which is required for Projects 3 and 4. In the third[unreadable] component, Core B will provide the animal care required for the animal models, including both the care required for[unreadable] maintaining health in chronically instrumented animals and maintenance of the breeding colonies of transgenic mice.[unreadable] The fourth function is administration, since this core services all projects and interacts closely with the other cores, and[unreadable] must meet the regulatory requirements for animal care. The breakdown is as follows: Projects 1 and 2 will use[unreadable] domestic swine (25 % of Core activity, but 30% of Core costs, for each project), Project 3 will use transgenic mice (30%[unreadable] of Core activity, but 25% of Core costs) (rats will be used for neonatal and adult myocyte culture), Project 4 will use[unreadable] transgenic mice (20% of Core activity, but 15% of Core costs).